Role of AMP-kinase pathway in the regulation of Minimal change disease-to-FSGS transition

Project Summary: Nephrotic syndrome (NS) is characterized by proteinuria and is associated with podocyte
actin cytoskeletal disorganization termed foot process effacement (FPE). Podocytes are incapable of self-
renewal, and podocyte loss above~40% per glomerulus associates with glomerulosclerosis (FSGS) and kidney
failure. Distinct from FSGS, Minimal Change Disease (MCD) also shows diffuse FPE, but has preserved
podocyte numbers, and is highly treatment responsive with a low rate of progression to ESRD (5-20% in 20
years). FSGS has been associated with glomerulomegaly and podocyte hypertrophy in later stages. However,
early FSGS can be morphologically indistinguishable from MCD and a debate exists whether some MCD cases
transition to FSGS, representing a “switch” between diseases. Hence, understanding signals specific to MCD
will reveal mechanisms facilitating podocyte survival and preventing a phenotype “switch”. Interestingly, Fyn
kinase inactivation was specifically identified in human MCD. In mice, Fyn inactivation (by Shroom3 silencing)
also associated with FPE without podocytopenia - an “MCD-like” pathology. Hence Fyn inactivation was a
candidate MCD-unique signal. Downstream of Fyn-inactivation, investigation of anti-hypertrophy and pro-
survival pathways in podocytes revealed enhanced activation of AMP-kinase, explaining these effects. Fyn
inactivation activated AMPK by increasing cytoplasmic efflux of LKB1. Moreover, inhibition of Ampk in MCD-like
mice induced podocyte loss, glomerulomegaly and FSGS, while AMPK activation prevented podocyte loss after
glomerular injury induced by hypertrophy and direct toxins. Invitro data show increased autophagy as the central
pro-survival mechanism in podocytes after AMPK-activation. We hypothesize that in the context of injury causing
podocyte FPE, AMPK signaling regulates the “switch” between MCD and FSGS by enhancing autophagy and
preventing podocytopenia. In this proposal, we will test the role of podocyte AMPK signaling in MCD vs FSGS,
and establish downstream mechanisms regulating podocyte survival. In Aim I, we will use genetic and
pharmacologic model systems to specifically inactivate or activate AMPK to induce phenotype changes from
MCD-to-FSGS and vice versa. In Aim-II, we will modulate autophagy in podocytes while activating AMPK to
show the central role of AMPK-mediated autophagy in podocyte survival. We will also specifically examine the
role of autophagy in restricting glomerulomegaly during injury. Finally, in Aim-III, applying state-of-the-art and
multidimensional technologies to the largest NS cohort in the US, we will investigate the specific role of AMPK
signaling in human MCD vs FSGS. Our work will provide novel MCD-FSGS diagnostics, and develop novel
AMPK therapeutics as well as help repurpose FDA-approved AMP-activators.

Public health relevance
Project Narrative: Nephrotic syndrome (NS) is an important cause of progressive renal failure with the notable exception of Minimal change disease (MCD), which is highly responsive to treatment in spite of having podocyte cytoskeletal injury similar to other NS. We identified AMP-kinase as a specific signal in MCD podocytes which enables their survival in spite of injury. Our work here will study a large case series of human NS to establish innovative diagnostic methods for MCD based on AMPK activity that will also have prognostic value, and use pharmacologic and genetic models to develop and repurpose AMP-Kinase activators for use in all NS.